ShEEP Request for Bruker BioSpec 3T MRI System Upgrade

The capability of performing longitudinal magnetic resonance imaging (MRI) on small animals in vivo significantly
and positively impacts a large number of VA-supported projects in basic, translational and preclinical
biomedical/behavioral research relevant to Veteran's healthcare currently conducted at the Jennifer Moreno
VA Medical Center (JMVAMC) (formerly known as the VA San Diego Healthcare System). We have a Bruker
BioSpec 3T small animal MRI system which is integrated into the centralized JMVAMC/Veterans Medical
Research Foundation Microimaging Core facility, but the current configuration is limited in its ability to perform
rapid scans, including the inability to perform high-quality mouse cardiac and mouse functional brain MRI
experiments. We are a group of 18 investigators with active VA funding who will directly benefit from upgrading
the existing Bruker BioSpec 3T MRI system. Our projects which will benefit from the upgrades encompass a
wide range of fields and research, including radiology, cardiology, orthopaedics, bioengineering, neurology,
psychiatry, pulmonology, endocrinology, gastroenterology, oncology, and surgery. Upgrading our small animal
MRI imaging system to the latest state-of-the-art system will not only impact basic pre-clinical research at
JMVAMC, but is also expected to have a strong and positive effect through improvement of patient clinical care.
The imaging techniques employed on our 3T system are readily incorporated to the clinic, ultimately supporting
the VA healthcare mission.

Public health relevance
Small animals are vital pre-clinical models in the Jennifer Moreno VA Medical Center (JMVAMC) (formerly known as the VA San Diego Healthcare System) research community and they enable the fundamental and translational investigation of mechanisms underlying an increasingly complex set of diseases and injuries that impact Veterans and their caregivers. Magnetic resonance imaging (MRI) is an especially important modality since morphology and composition of nearly any organ can be evaluated. Upgrading the currently limited system will allow several new JMVAMC researchers to incorporate non-invasive MRI into their studies, including mouse cardiac and functional brain MRI, while dramatically accelerating acquisition for existing users. The upgrades will increase our scientific productivity and also offer faster bench-to-bedside translation as the imaging techniques employed on our 3T system are readily incorporated to the clinic, ultimately improving Veteran care.